Elucidating how a USP9X-COP1 axis regulates RIT1 protein abundance and reveals druggable targets in lung adenocarcinoma

PROJECT SUMMARY
Targeted therapies have revolutionized cancer treatment and are becoming standard of care over
cytotoxic chemotherapy. In lung cancer, where approximately 50% of tumors harbor druggable mutations in
genes such as EGFR and ALK, targeted therapies are highly effective at reducing tumor burden; however, many
mutations are not clinically actionable. Up to 13% of lung adenocarcinoma tumors are driven by mutation or
amplification of the RAS-family protein RIT1, and RIT1 mutations do not co-occur with other canonical driver
mutations. Because of this, there is a major unmet clinical need to identify effective targeted therapies for patients
with RIT1-driven diseases.
My career goal is to become a translational research scientist focused on identifying novel therapeutic
options for cancer patients. The lack of therapeutic strategies for the treatment of RIT1-mutant lung cancer offers
opportunities for me to build the skills, techniques, and expertise to address this problem and move towards my
career objectives. This motivation led me to my thesis lab, where Dr. Berger developed a genome-wide CRISPR
screening assay in human RIT1-mutant lung cancer cells. I helped analyze the CRISPR screen data and
identified the deubiquitinase (DUB) USP9X and the E3 ligase COP1 as key regulators of RIT1 function. Validation
experiments confirmed that individual loss of USP9X reverses RIT1-induced cell survival in lung cancer while
loss of COP1 maintains RIT1-driven drug resistance. The results of the CRISPR screen provide rigorous, key
support for this proposed project. Recent work suggests that the protein abundance of RIT1 is important for its
oncogenic function; however, the exact DUBs and E3 ligases involved in regulating mutant RIT1 protein
abundance have yet to be fully elucidated. Driven by this question, I initiated experiments to confirm that genetic
knockout of USP9X decreases the abundance and stability of RIT1. I have also found that pharmacological
inhibition of USP9X in vitro reduces RIT1 protein abundance, and preliminary in vivo experiments revealed that
USP9X loss abrogates RIT1-driven xenograft tumor formation. Additionally, work from our collaborators
demonstrates that RIT1 physically interacts with USP9X and COP1. Together, these data propose a regulatory
axis of RIT1 protein abundance mediated by USP9X and COP1. I hypothesize that USP9X de-ubiquitinates
and stabilizes RIT1 and that COP1 counteracts this regulation. Pharmacological inhibition of USP9X could
therefore specifically target oncogenic RIT1. Ultimately, this work will reveal a novel mechanism of RIT1 protein
regulation and could uncover the utility of USP9X inhibitors to address a major unmet clinical need for patients
with RIT1-mutant or -amplified diseases. This project will build upon my skills in genomics and biochemistry while
providing necessary training with in vivo murine systems. I will be able to translate my findings at the bench to
mouse models, thereby expanding my skills in translational research and furthering my career objectives to
become a senior scientist in an industry setting, working on developing new and better cancer treatments.

Public health relevance
PROJECT NARRATIVE RIT1 mutations and amplifications account for nearly 13,000 annual deaths from lung adenocarcinoma worldwide, but little is known about RIT1’s oncogenic function. This research is poised to identify a novel mechanism of RIT1 protein regulation mediated by the deubiquitinase USP9X and the E3 ligase COP1. In addition to furthering our understanding of RIT1 biology, this work could also lead to the first RIT1-targeted therapy for any disease, fulfilling a critical unmet medical need.